Machine learning analyses of single-cell multi-modal data for understanding cell-type functional genomics and gene regulation

Project Summary
Understanding cell-type-specific gene functions, expression dynamics, and regulatory
mechanisms in complex brains is still challenging. To this end, the increasing amount of single-
cell multi-modal data in the BRAIN Initiative allows a better understanding of molecular and
cellular mechanisms that occur in various cellular phenotypes such as electrophysiology,
transcriptomics, and morphology. Many computational methods have thus been applied to
integrate such multi-modal data for discovering genes, functions, and cross-modal cell types.
However, many of these methods output descriptive results such as differentially expressed
genes of various cell types, barely providing functional and regulatory mechanistic insights. The
multi-modal data from different studies potentially give rise to inconsistency and bias and lack
interpretability for understanding mechanisms. It is crucial to integrate and analyze single cell
multi-modal data using coherent, biologically interpretable methods to address these problems.
Thus, the objective of this project is to perform machine learning analyses to integrate single-
cell multi-modal data in the BRAIN Initiative for predicting the gene functions and gene
regulatory networks for cellular phenotypes and improving phenotype prediction. Our machine
learning analyses in this project can further serve the BRAIN Initiative project to enable multi-
modal data integration and discover functional biomarkers (e.g., genes, regulatory elements,
pathways) for various cell types and cellular phenotypes. These cell-type biomarkers will
provide an increased understanding of complex brain mechanisms that potentially lead to novel,
testable, mechanistic, and translational biological hypotheses. We will have three aims to
accomplish this project. In Aim 1, we aim to apply manifold learning analysis to align single-cell
multi-modalities and reveal cell trajectories with continuous phenotypic changes such as gene
expression and electrophysiology. In Aim 2, we aim to predict cell-type gene regulatory
networks for multi-modal characteristics. In Aim 3, we will apply the deep learning analysis to
improve cellular phenotype prediction from multi-modal data and prioritize cell-type gene
regulatory mechanisms for phenotypes. Finally, all of our analyses will be open source and
publicly available as general bioinformatics tools.

Public health relevance
Project Narrative The underlying functional genomics and gene regulatory mechanisms driving various cellular phenotypes in complex brains remain elusive. This project aims to use machine learning analyses to integrate single-cell multi-modal data in the BRAIN Initiative to predict gene expression changes, gene functions, and regulatory networks for cellular phenotypes and improve phenotype prediction. The BRAIN Initiative and community can further use our analyses as general tools to identify potentially novel cell types, discover marker genes and functions and predict regulatory networks as additional cellular phenotypes, advancing our understanding of cellular and molecular mechanisms in the brains.